Skin Biology and Diseases Resource-based Center at Mount Sinai

Summary - Overall
The overall goal of the Skin Biology Resource-Based Center (SBDRC) at Mount Sinai is to accelerate research
in skin biology and diseases and promote its translation to benefit human health. To achieve this, we will
harness the technical innovations, high-end infrastructure and computing power available at Mount Sinai to
specifically advance and innovate skin research. In parallel we will ensure a vibrant future for skin biology and
diseases research by expanding our research community and increasing its diversity. Administrative Core A
will provide management, structure and oversight; award User Scholarships to reduce cost barriers to high end
technologies; communicate SBDRC programs through a website and social media; organize research talks,
seminars and retreats to promote scientific interchange and collaborations; attract new investigators and
support development of junior and physician-scientists through Pilot Grants and Individual Mentoring
Committees; and improve diversity through Mount Sinai's newly established Laureates Program that facilitates
targeted faculty recruitment, and by establishing the SBDRC Sinai Skin Scholars Program, which will introduce
underserved East Harlem high school students to skin biology and diseases research. Our Resource Cores
are designed to capitalize on Mount Sinai's institutionally-supported and highly innovative technological
infrastructure and expertise. We will support effort for technological experts to prioritize SBDRC goals and
immerse themselves in skin research labs. Each Resource Core will provide unique expertise from leaders in
diverse research areas, and technology, training and services customized to users' needs. The 3 Resource
Cores will interact seamlessly: Resource Core B, “Modeling of Skin Disease for Mechanistic Analysis and
Therapeutic Discovery,” will facilitate access to human skin samples, and provide technology, consultation
and assistance with multiplexed immunostaining, isolation of skin cell subpopulations, generation and analysis
of genetic mouse models, and gene editing and gene expression manipulation in human iPSC-derived skin
cells. Skin cells or samples from Core B will be analyzed at the molecular level in Resource Core C, “Skin
Genomics, Transcriptomics, and Epigenetics Core,” which will provide access to genomics (exome
sequencing, whole genome sequencing, and targeted capture), transcriptomics (RNA-seq, ISO-seq, small
RNA seq), epigenetic (ATAC-seq, ChIP-seq, CUT&RUN, Hi-C), and single-cell (scRNA-seq, scATAC-seq,
spatial transcriptomics) technologies. Resource Core D, “Data Analysis and Integration Core,” will provide
standardized biostatistical and bioinformatics analysis and integration of Core C data and make these easily
available through Skin-GLOW, a novel user-friendly interface for data visualization. In turn, data analyzed in
Core D will yield candidate genes and mechanisms that will be tested through functional analyses provided in
Core B. Our plans will create a productive, impactful and extensive skin Research Community including strong
external hubs at NYU and at Yale University.

Public health relevance
Project Narrative - Overall The overall goal of the Skin Biology Resource-Based Center (SBDRC) at Mount Sinai is to accelerate research in skin biology and diseases and promote its translation to benefit human health. To achieve this, we will harness the technical innovations, high-end infrastructure and computing power available at Mount Sinai to specifically advance and innovate skin research by lowering cost barriers for skin researchers to access advanced technologies; embedding gene editing, genomics and bioinformatics experts in skin research labs to break down interdisciplinary communication barriers; and providing in person and virtual venues to facilitate collaboration and exchange of ideas. In parallel we will ensure a vibrant future for skin biology and diseases research by aiding entry of outside investigators through training and financial support; promoting development of junior investigators and physician-scientists; and enhancing the diversity of our research community through targeted recruitment and mentoring of minority scientists and by growing the pipeline of young minority students entering the field.